REEVALUATION OF LONG-TERM SURVIVORS WITH DILATED CARDIOMYOPATHY

Between 1982 and 1988 the NHLBI, the NIAID, and the Clinical Center conducted a prospective randomized trial of anti-inflammatory therapy in idiopathic delated cardiomyopathy. By 1992, after 6 to 9 years of followup, 67 of the 123 patients had died and another 23 had undergone cardiac transplantation. Of the remaining 33 non-transplanted survivors, almost half were asymptomatic. This protocol (93-CC-OO96) involves non- invasive followup re-evaluation of these 33 patients, including radionuclide cineangiography echocardiography, Holter monitoring, and exercise testing. When completed, this study will represent the first prospective description of the long-term natural history idiopathic dilated cardiomyopathy in a well-characterized cohort of referral patients. Objective data concerning cardiac size and cardiac function among long- term survivors will permit clinicians to advise newly diagnosed dilated cardiomyopathy patients regarding their prospects for long-term remission.